Beyond demographics: Mixed-methods research for effective communication tools to prevent tobacco use in Hispanic adolescents and young adults

PROJECT SUMMARY Health communication campaigns are a critical part of tobacco control policy, but may exacerbate health disparities if they are not thoughtfully designed. Specifically, communication campaigns tend to benefit more advantaged populations (e.g., non-Hispanic white, higher SES) while failing to reach or resonate with more disadvantaged populations. Moreover, these disadvantaged populations are exposed to tobacco marketing at disproportionately high rates. These communication inequalities can result in disparities in the rates of tobacco use. To address these health disparities, tobacco prevention campaigns must (1) be based on in-depth formative evidence in order to reach and resonate with groups most at risk for tobacco use, and (2) successfully compete with and counteract the effects of pro-tobacco marketing. This requires going beyond simple demographic targeting (by race, SES, etc.) to produce messages that deeply resonate with the target population’s social and cultural lives. To accomplish this, the proposed study uses an innovative blend of methods to understand tobacco use among Hispanic adolescents and young adults. Hispanics have higher rates of susceptibility to tobacco use, and comprise approximately one quarter of the US youth population, making them an important group for tobacco control. Moreover, much research on Hispanics fails to examine the considerable differences in this population by ethnic heritage (e.g., Mexican, Cuban, etc.). The current project will (Aim 1) Identify unique and cross-cutting psychological, social and cultural influences on tobacco use among Hispanic youth and young adults at-risk for tobacco use, and (Aim 2) Describe the pro-tobacco communications environment to which Hispanic youth are exposed. Aim 1 will be accomplished through a mix of online discussions and in-person focus groups. Online discussions are an innovative technique that allow us to obtain a diverse sample of Hispanic 15-21 year olds to examine key sub-group differences. In-person focus groups will be held in four US MSAs with the highest number of Hispanics. The in-person focus groups allow us to focus more intensely on key themes identified in the online discussions. The focus groups will use innovative techniques to access thoughts, opinions and motivations that may be difficult for participants to articulate, and will produce a deep understanding of tobacco use in this population. Aim 2 will conduct a content analysis of tobacco marketing targeting Hispanics. We will use data from the content analysis to identify key marketing tactics, and will obtain focus group participants’ perspectives on these tactics. Ultimately, these findings will be disseminated to stakeholders in collaboration with our partners at Campaign for Tobacco-Free Kids (CTFK). We will develop an online toolkit that stakeholders can access on-demand, webinars to provide more focused education, and will work with CTFK to integrate our findings into their trainings. Ultimately, this project will produce novel, in-depth information to support efforts to communicate more effectively about tobacco with Hispanic youth and young adults, and to restrict tobacco marketing targeting youth.

Public health relevance
PROJECT NARRATIVE The proposed project addresses communication inequalities that underlie tobacco-related health disparities. We will use an innovative blend of online discussions, in-person focus groups, and content analysis to generate sociocultural maps to tobacco use among Hispanic youth and young adults. With our study partners at Campaign for Tobacco-Free Kids and youth advisory board, we will disseminate these findings to stakeholders in the US to support tobacco prevention campaign development and efforts to restrict tobacco marketing.